Cleveland Precision Medicine Chronic Kidney Disease Cohort

Goals. The Cleveland Chronic Kidney Disease Recruiting Site (CLE-CKD-RS) has been a member of the KPMP
since its inception 5 years ago and will continue to recruit a cohort of CKD patients with diabetic kidney disease
(DKD) and hypertension-attributable CKD (H-CKD), building on our demonstrated successes. To meet our
proposed recruiting targets, we will expand patient screening to the Cleveland Clinic main campus general
medicine clinic and CKD clinics in regional facilities, focusing on sites that serve minority communities. The CLE-
CKD-RS will strengthen and broaden its relationships with diverse communities to foster trust and ensure the
Cleveland KPMP cohort reflects the people most burdened by kidney diseases.
Background. Kidney diseases are common, costly and deadly. The Kidney Precision Medicine Project (KPMP)
is building a resource, which will have patient-level clinical datasets and molecular phenotypes, to identify hidden,
clinically actionable subgroups of people with kidney diseases for discovery of mechanisms, biomarkers and
new treatments. The KPMP hypothesizes proposes integration of multidimensional patient data, omic level
molecular data and variation in genome sequence will generate tools necessary for needed innovation.
CLE-CKD-RS: synergy with and value to KPMP. In the first funding cycle the CLE-CKD-RS research team has
successfully executed KPMP protocols to ethically and safely enroll, biopsy and retain a diverse cohort of KPMP
participants. In addition, The CLE-CKD-RS has established an engaged Community Advisory Board and used
opportunities to educate the medical and patient communities about the KPMP, the burden of kidney diseases
and approaches to promote kidney health. Although KPMP activities were first suspended and then slowed by
the public health response to the COVID pandemic, the CLE-CKD-RS used telehealth tools to follow our cohort
and rapidly restarted activities when permitted. This experience has prepared for future black swan events.
Members of the CLE-CKD-RS team serve on KPMP working groups and committees as members and leaders.
We participate in two CKD extended clinical phenotyping studies funded by the Opportunity Pool funds and
engaged other local investigative groups to join the KPMP by winning Opportunity Pool funding. Building upon
these successes, we are proposing the following Milestones:
1. Safely and ethically collect 30-40 research kidney biopsies per year from eligible individuals with H-CKD
or DKD with target aggregate enrollment of 180 CKD participants for the 5 year funding period.
2. Retain 90% of enrolled participants in research follow-up visits and activities throughout the funding cycle.
3. Initiate KPMP recruitment at CKD clinics in regional sites that serve the Black and Hispanic communities
in years 6 and 7, respectively and maintain recruitment at those sites for the duration of the funding cycle.
4. Broaden in person, expand virtual and live community engagement activities for education and reciprocal
interactions about kidney health, KPMP participation and biomedical research in general.

Public health relevance
PROJECT NARRATIVE Kidney diseases affect 37 million Americans, their causes remain incompletely understood and treatments are limited. The Kidney Precision Medicine Project (KPMP) aims to identify new treatments for common causes of kidney disease by ethically collecting kidney biopsies and clinical information to create a kidney atlas with roadmaps describing cell function in health and disease. The Cleveland Chronic Kidney Disease Recruiting Site has been in the KPMP since its inception and will continue to recruit and follow people with chronic kidney disease from hypertension and or diabetes to create a cohort that represents disproportionately affected communities.